Reward, impulsive sensation seeking and emotional dysregulation: neural mechanisms underlying risk for bipolar disorder in young adults

Bipolar Disorder (BD) is often misdiagnosed as Major Depressive Disorder (MDD) and poorly-treated. As
risk for mental health problems increases in young adulthood, identifying objective neural marker predictors
of future BD vs. MDD in young adults will provide neural markers for early risk identification and neural
targets for new interventions to delay or prevent these debilitating disorders. The goal in the initial MERIT
Award period was to adopt a transdiagnostic and dimensional approach to identify neural marker correlates
and predictors of worsening manic/hypomanic vs. depressive symptoms in young adults, ultimately to
distinguish BD from MDD risk. We showed that: elevated reward expectancy-related left ventrolateral
prefrontal cortical (vlPFC) and prediction error-related left ventral striatal activity, lower PE-related right
amygdala activity, and lower bilateral cingulum bundle fractional anisotropy (FA), a measure of white matter
fiber collinearity, predicted current and/or future mania/hypomania; greater largescale (central executive
[CEN], salience and default mode) network functional connectivity (FC) and greater CEN dorsolateral
prefrontal cortical (dlPFC) activity during emotional regulation predicted current and future depression;
while lower right uncinate fasciculus FA and greater left vlPFC and lower left inferior temporal cortical
thickness were associated with greater mania/hypomania and depression. In the proposed MERIT
extension, to yield robust neural markers of BD vs. MDD risk, we aim to examine: 1. an independent young
adult sample (n=150 non mood disordered 18-30 year-olds) to test findings; 2. higher temporal resolution
neural, and dopamine transmission, measures using fMRI-based source-localized electroencephalography
(EEG) beta power/FC and midbrain neuromelanin contrast to noise ratio; 3. longitudinal neuroimaging to
identify neural change predictors of worsening mania/hypomania and depression, and ultimately BD and
MDD; 4. relationships among neural measures, response tendencies and symptom trajectories
predisposing to BD and MDD, to better understand risk pathways for these disorders; and 5. young adults
with 1st and/ or 2nd degree relatives with BD and MDD/ MDD, given their higher BD and MDD risk.
RELEVANCE (See instructions):
Bipolar Disorder (BD) is often misdiagnosed as Major Depressive Disorder (MDD). The proposed MERIT
extension aims to study a new sample of young adults at familial risk of BD and/or MDD using more
sensitive measures of brain activity and repeated brain scans, to test present findings, identify robust brain
markers of BD vs. MDD risk, improve early BD risk identification, and aid new treatment development.

Public health relevance
RELEVANCE (See instructions): Bipolar Disorder (BD) is often misdiagnosed as Major Depressive Disorder (MDD). The proposed MERIT extension aims to study a new sample of young adults at familial risk of BD and/or MDD using more sensitive measures of brain activity and repeated brain scans, to test present findings, identify robust brain markers of BD vs. MDD risk, improve early BD risk identification, and aid new treatment development.